Leadership, Planning and Evaluation

The Leadership, Planning and Evaluation component of the Cancer Center Support Grant (CCSG) develops and implements a vision for the University of Chicago Medicine Comprehensive Cancer Center (UCCCC), and addresses Center’s overall goals, policies and operations. It serves as the framework for obtaining effective internal and external advice, setting priorities, making decisions and defining, evaluating and executing the Strategic Plan. Significant and substantial changes took place in Senior Leadership over the past funding period. Kunle Odunsi, MD, PhD, a well-regarded physician/scientist with immense Cancer Center experience, was recruited as Director of UCCCC in March 2021. Odunsi identified a new Deputy Director and 5 new Associate Directors (ADs), 1 of which is a new position: AD for Shared Resources. Senior Leadership sets the goals with guidance from the Executive Committee, program leaders, component leaders, community members, as well as internal and external advisory committees. During the current funding period, the Senior Leadership Team led a comprehensive strategic planning and evaluation effort. This resulted in a five-year Strategic Plan (2022-2027), that robustly aligns programmatic initiatives and organizational priorities for the Cancer Center. A formal External Advisory Committee (EAC) meets annualy, along with mini-EAC Retreats throughout the year addressing specific components of the CCSG, to provide objective evaluation and advice to the Director. The external advisors are appropriately balanced for basic laboratory, clinical, prevention, cancer control and population science and administrative expertise. UCCCC led seminars, retreats and workshops aim to stimulate transdisciplinary research opportunities and assessment of implementation of strategic goals. The aims of Leadership, Planning and Evaluation are: (1) To establish a leadership structure to support the UCCCC mission; (2) To engage in planning and development of a unified Strategic Plan and develop tactics to execute strategic decisions and oversee implementation of the Strategic Plan; (3) To track success, implement change, and evaluate performance of the UCCCC using external and internal advisory groups. Overall, Odunsi and the UCCCC Senior Leadership team have effectively utilized the Cancer Center Support Grant to put in place a vigorous and robust process of vision setting, evaluation of progress, implementation of improvements, and planning for the future.